Acute and Critical Care Engineering (ACCE) Training Program

PROJECT SUMMARY
Acute and critical care is a time-sensitive medical specialty where providers leverage biomedical technologies
to save severely ill and injured patients and restore their functioning after a life-threatening accident or sudden
medical emergency. Acute and critical conditions account for ~40% of hospital costs, highlighting the ongoing
need for new biomedical innovations that can help providers make rapid clinical decisions, diagnose, monitor,
and treat critically ill and injured patients. However, the complex and urgent nature of acute and critical care
presents distinct technical and engineering challenges that most engineers are not currently trained to address.
The goal of this new Acute and Critical Care Engineering (ACCE) Training Program is to equip Engineering
doctoral students to collaboratively develop, test, and commercialize medical innovations that fulfill the unique
design and engineering requirements of acute and critical care technologies. This program will provide trainees
with a foundation in key engineering principles and techniques; understanding of the clinical and technological
issues in acute and critical care; and rigorous research and commercialization skills to translate rapid, precise,
easy-to-use, point-of-care tools to the patient bedside. We will enroll 2 pre-doctoral Engineering students each
year (typically in their second year of graduate education), and each trainee will complete ACCE over 2 years.
This interdisciplinary program will be jointly housed in the College of Engineering and the Weil Institute for
Critical Care Research and Innovation, bringing together engineering, medical, and other disciplines.
ACCE Program objectives are: 1) provide coordinated interdisciplinary research mentorship from a primary
mentor in the College of Engineering and at least one secondary mentor in the Medical School; 2) provide
tailored curriculum tracks based on trainees’ technological focus (either health IT, diagnostic/monitoring tools,
or therapeutic devices), with each track comprising engineering, design, and biomedical coursework relevant to
the technology area; 3) provide valuable insights into the unique clinical setting and technological needs within
acute and critical care through our ACCE Clinical Immersion Program; 4) provide targeted training in the
unique design requirements of acute and critical care technologies via a bi-monthly ACCE Design Studio; 5)
provide coursework, guidance and workshops in product development and commercialization as well as
optional biomedical industry internships to ensure trainees understand major principles of biomedical
translation; 6) provide opportunities for interdisciplinary networking and feedback through other ACCE events
(Journal Club, Annual Symposium); and 7) provide career development and leadership curriculum
emphasizing responsible conduct of research, rigor and reproducibility, collaboration, oral and written
communication, and grant writing skills. Due to the unique opportunities, skills, and knowledge provided by the
ACCE Program, we expect graduates will be highly sought after for academic and industry research positions.

Public health relevance
PROJECT NARRATIVE Millions of patients suffer from life-threatening accidents and sudden medical emergencies every year, and the technologies used to diagnose, monitor, and treat these patients have special engineering requirements compared to technologies for any other health condition. Given the abruptness and urgency of acute illnesses and injuries, technologies must work very rapidly, be highly accurate, and be easy to use by various medical personnel both in and outside the hospital (e.g., in ambulances), yet students are rarely taught how to address these unique design issues. The new Acute and Critical Care Engineering (ACCE) Training Program will provide Engineering pre-doctoral students with interdisciplinary mentorship, specialized curriculum tracks, clinical immersion, focused design training, and entrepreneurial workshops, equipping them to address these engineering challenges and collaboratively develop, test, and commercialize new life-saving technologies.